Yale Liver Center

PROJECT SUMMARY – OVERALL
This is a renewal application for support of the Yale University Digestive Disease Research Core Center, a
multidisciplinary Center whose research focus is Liver Structure, Function and Disease. Thirty-four
independently funded investigators comprise a current digestive disease related-research base of ~$23 million,
and all of these individuals actively collaborate with other Liver Center members. There are an additional 52
associate members engaged in liver-related research, 40% of whom also have independent funding. Research
programs in the Center are distributed across 17 Departments of the University including Biomedical
Engineering; Cell Biology; Cellular and Molecular Physiology; Comparative Medicine; Epidemiology and Public
Health; Human Genetics; Immunobiology; Internal Medicine; Microbial Pathogenesis; Molecular Biophysics and
Biochemistry; Obstetrics and Gynecology; Pathology; Pediatrics; Pharmacology; Radiology, Surgery, and
Urology. The research base focuses on three major basic/translational themes: (1) Hepatic metabolism, (2)
Immunobiology and inflammation, and (3) Epithelial biology/pathobiology. The research programs are broad and
range from fundamental studies of the biology of liver and related digestive systems to translational studies of
immediate clinical relevance. The major areas of liver disease examined within these translational themes
include autoimmune diseases, cholestasis, fibrosis/cirrhosis, genetic diseases, infections, liver cancer, and
NASH/ASH. The major goals of the Center continue to be: (1) to stimulate multidisciplinary interactions between
basic and clinical faculty and departments, (2) to provide an in-depth training environment, (3) to efficiently
organize time consuming, often costly techniques and procedures in Core Facilities for use by multiple
investigators, (4) to stimulate basic scientists to direct their focus to areas of interest to the Center, (5) to stimulate
translational research from bench to bedside, (6) to promote new research and training opportunities with a pilot
feasibility program, and (7) to create an intellectual environment within the field by fostering collaborations both
within and outside the institution through its enrichment program. To achieve these goals the Center is organized
into four Core Facilities including: (1) Administrative Core, (2) Cellular and Molecular Physiology Core, (3)
Morphology Core and (4) Clinical/Translational Core. A Pilot Feasibility Program supports one- to two-year small
grants for new scientific initiatives. The Enrichment Program consists of research seminars, symposia, visiting
professorships, and retreats.

Public health relevance
PROJECT NARRATIVE – OVERALL Liver disease affects nearly one in three Americans. The Yale Liver Center's mission is to enhance knowledge of the etiology, diagnosis and treatment of liver diseases and other related disorders of the digestive system, thereby advancing the nation's public health. It does so by simulating both basic, translational and clinical research in this discipline at the University and by establishing core research facilities for use by multiple liver investigators.